MALIGNANT CHANGES ASSOCIATED WITH SCLEROSING ADHESIONS

Sclerosing adenosis is a proliferative breast lesion with pseudoinvasive features frequently misdiagnosed as infiltrating carcinoma. The purpose of this study will be: 1) evaluate the premalignant potential of this lesion; 2) its association with carcinoma and 3) evaluate the integrity of the basement membrane. Patients with sclerosing adenosis in which in situ cancers develop are probably at a much higher risk to evolve to an invasive cancer.